Chemical Approaches to Understanding the Mechanisms of Iron-Sulfur Enzymes

Project Summary/Abstract
Enzymes with iron-sulfur (Fe-S) clusters in their active sites catalyze myriad transformations relevant to human health and
disease. Identifying disease targets and designing inhibitors requires an in-depth understanding of their reaction
mechanisms, which in turn requires both molecular-level characterization of resting states and intermediates as well as
comparison with structurally and functionally faithful synthetic models. This project entails both advancing the synthetic
modeling chemistry of Fe-S proteins and developing new methods for improving the information content of spectroscopic
data on Fe-S proteins.
In the context of modeling the chemistry of Fe-S enzymes, we will synthesize clusters whose geometric structures closely
resemble those of enzymatic intermediates and whose spectroscopic data can be compared with the data acquired on natural
systems. In addition to using models in this manner (i.e., for structure elucidation), we will formulate hypotheses regarding
the electronic structures of these intermediates and the factors that dictate their diverse reactivity patterns, and we will test
these hypotheses by harnessing the exquisite tunability of synthetic chemistry to rationally altering the clusters’ properties
and reactivity. Overall, this part of the project will combine synthesis, spectroscopy, and mechanistically oriented reactivity
studies to shed light on the mechanisms of Fe-S enzymes.
Regarding our biological work, we first note that although 57Fe Mössbauer and 57Fe ENDOR spectroscopy can be
exceptionally powerful in characterizing intermediates of Fe-containing enzymes, the high nuclearity of Fe-S clusters can
limit the usefulness of such techniques because the signals arising from multiple metal sites can be challenging to resolve.
This is true of resting states and is especially problematic when analyzing mixtures of reaction intermediates. Moreover, it
is often impossible to map spectroscopic responses to specific sites in the geometric structure, and this severely limits our
understanding of the chemical bonding—and therefore the reactivity—of biological Fe-S clusters. We propose to address
these challenges by developing methods for incorporating 57Fe into specific sites of biological Fe-S clusters. Doing so would
make Fe-S proteins as spectroscopically tractable as mononuclear Fe-containing enzymes, and would thereby greatly
enhance our mechanistic understanding of Fe-S proteins. In addition to developing the methodology, we will use the site-
selectively labeled samples generated in this project to study reactive intermediates and inhibitor-bound states of Fe-S
enzymes of relevance to human health and disease.

Public health relevance
Project Narrative Enzymes that bind iron–sulfur clusters are found in all kingdoms of life and perform reactions that play central roles in human health. To understand the mechanisms of Fe-S enzymes, we will generate and study synthetic models of reactive intermediates and perform mechanistic studies on Fe-S enzymes featuring spectroscopically useful isotopes placed in structurally well-defined sites.